Apoptotic Regulation and Neuroinflammation in Alzheimer's Disease

Project Summary
In patients with Alzheimer’s disease (AD), the progressive loss of neurons over time leads to memory loss and
other devastating symptoms. Neuronal loss and inflammation in AD are strongly correlated with advanced age,
but it remains unknown how age contributes to neuronal cell death or how cell death and neuroinflammation
might be linked. This knowledge gap exists in part because previous studies of apoptosis, the canonical regulated
cell death pathway, have A) lacked a functional assay to measure the apoptotic sensitivity of cells in the brain
and B) relied on readouts of apoptosis that may not be present in neurons or other AD-affected cell types. The
goal of my research is to better understand the regulation of apoptosis in the aging brain, investigating the links
between aging, AD, inflammation, and apoptosis. Specifically, I propose to use BH3 and caspase profiling (BCP),
a functional measurement of apoptotic sensitivity, and other methods to investigate the hypothesis that increased
initiation of apoptosis in aging and AD promotes cell death and inflammation in neurons lacking apoptotic
caspases. In Aim 1, I will quantify apoptotic priming, caspase activity, and inflammatory signaling in aged mice,
measuring changes in each over lifespan and testing the role of the BCL-2 family protein BAX in these changes.
In Aim 2, I will investigate these phenomena in human induced pluripotent stem cells (iPSCs), testing the effects
of familial AD mutations and modulation of the cGAS/STING signaling pathway. In Aim 3, I will use BCP and
other methods to study apoptotic priming and caspase competence in rapid autopsy human brain tissue,
investigating potential differences in initiation and execution of apoptosis in neural cells between AD patients
and healthy donor controls. The completion of these three aims will generate important new insights into the
regulation of apoptosis in aging and AD, potentially revealing new opportunities for therapeutic intervention.
The training plan for the proposed fellowship is designed to prepare me to lead my own research laboratory
studying cell death in aging and neurodegeneration. This plan includes career development and training in
laboratory methodologies, subject matter expertise, bioinformatic analysis, and classroom teaching. These
training opportunities are made possible by my selection of Dr. Kristopher Sarosiek and Dr. Mark Albers as
mentors, allowing me to draw on their expertise in their respective fields of cell death and neurodegeneration. I
have sought out additional guidance and support from the faculty comprising my Career Development Committee
and Scientific Advisory Committee, forming a strong network of mentors and collaborators. The research and
training environment of the Harvard School of Public Health provides an ideal setting for the proposed activities,
and I will draw on all these resources to complete the research and training plans described herein.

Public health relevance
Project Narrative Alzheimer’s disease (AD) affects 11% of Americans over the age of 65, and gaps in our understanding of the molecular mechanisms underlying this disease have prevented the development of effective therapeutics. In particular, the changing regulation of cell death in the brain during aging or in AD is an underexplored area. This proposal aims to illuminate the links between aging, AD, cell death, and inflammation, eventually enabling new therapeutic approaches to AD that can develop from an improved mechanistic understanding of cell death regulation in the brain.